Developing Hyperpolarized Nitrogen-15 MRI Agents for Probing Glutamine Metabolism

TITLE: Developing Hyperpolarized Nitrogen-15 MRI Agents for Probing Glutamine Metabolism
PROJECT SUMMARY/ABSTRACT
Glutamine is the most abundant free amino acid in the body. Glutamine has a versatile role in cell
metabolism, participating in tricarboxylic acid (TCA) cycle supplementation and the biosynthesis of nucleotides,
glutathione (GSH), and other nonessential amino acids. It is increasingly recognized that quantification of
glutamine metabolism is abnormal in multiple diseases including cancer, diabetes, and neurodegeneration.
Glutamine deprivation suppresses cancer growth and even induces cell death in several cancers. Various
cancers develop glutamine dependence and addiction to maintain continuous growth, survival, invasion,
metastasis, and resistance to cancer treatments. Imaging agents for effectively monitoring the stepwise
metabolic process of glutamine in vivo will have significant impacts for a better understanding of glutaminolysis
and their contribution to cancers.
Our long-term goal is to develop hyperpolarized 15N-MRI probes for abnormal metabolism for diagnosis and
treatment of diseases. The objective of this proposal is to develop nitrogen-15 (15N)-labeled probes that are
capable of monitoring the stepwise process of glutamine metabolism by hyperpolarized (HP) magnetic
resonance spectroscopy and imaging (MRS/MRI). Toward this goal, we will design, synthesize, and optimize
novel 15N-labelled probes, with Aim 1 targeting the conversion of glutamine to glutamate by glutaminase and
Aim 2 targeting the glutamine-derived production of alpha-ketoglutarate and 2-hydroxyglutarate. These 15N-
labelled probes will be evaluated on their potentials as effective imaging agents to deliver long-lived
hyperpolarized 15N NMR signals for sensitive and specific detection of the targeted metabolic step. Overall
impacts of this R21 grant are two-fold. First, the developed HP 15N-MRI agents will advance the ability of imaging
glutamine in vivo, convey more accurate and comprehensive information of abnormal glutaminolysis, and offer
new metabolic biomarkers for cancers. Second, the successful in vivo imaging by 15N-tagged HP-MRI probe will
unbridle 15N-MRI agents from traditional limitations restricted to 15N-isotope labeled nitrogen atoms in
heteroarenes and peralkylatedamines, to achieve much greater potentials and broader applications in basic
biomedical and translational research.

Public health relevance
PROJECT NARRATIVE Glutamine is the most abundant free amino acid in the body and plays versatile roles in cellular metabolism, participating in tricarboxylic acid (TCA) cycle supplementation and the biosynthesis of nucleotides, glutathione (GSH), and other nonessential amino acids. Assessment of in vivo glutamine metabolism is fundamentally important and have significant impacts for understanding glutaminolysis and multiple diseases that are associated with abnormal glutamine metabolism including cancer, diabetes, and neurological disorders. To address the critical need for non-invasive agents for effectively imaging glutamine metabolism in vivo, we will develop novel nitrogen-15 (15N)-labeled probes that can monitor the different metabolic steps of glutamine deliberately by hyperpolarized (HP) magnetic resonance imaging (MRI).